Center Administration Core

Summary
The Administrative Core A will serve as the organizing core of the Center for Systems-level Study of
Metastasis. Administrative Core A will be located at Rockefeller University and will manage the administrative,
financial and programmatic aspects of the Projects and Cores of the Center. It will also coordinate sharing of
research findings and resources amongst the investigators of the Center and will communicate to the broader
NCI MetNet centers, NCI leadership and will provide outreach to the broader community of NCI metastasis
centers. The structure of Administrative Core A will consist of an Executive Board, an External Advisory
Committee, a Center Administrator and a Center Data manager.
The first aim of Administrative Core A is to manage the logistics and communication for the Center by
i) facilitating internal communications between the investigators of the 3 projects and the Single-Cell
Sequencing and Computational Core,
ii) enhancing external communications with NCI staff and MetNet centers,
iii) preparing documents for Center activities, including annual reports for the NIH and the External
Advisory Committee and iv) enhancing communications with collaborating scientists and physician-
scientists at other institutions.
The second aim of Administrative Core A is to coordinate activities within the Center and with other MetNet
centers by
i) scheduling and coordinating weekly meetings, where each project will be discussed monthly,
ii) scheduling and coordinating quarterly meetings of the Executive Committee,
iii) organizing annual meetings of the Center and External Advisory Committee and
iv) establishing an internal web site for communications amongst Center investigators and an external
website for reporting on publications, goals of the Center and protocol for requesting reagents.
The third aim of the Administrative Core A is to track and evaluate the progress of the Center by
i) assessing progress of the three Projects and that of the Single-cell Sequencing and Computational
Core and Intra-Center Pilot Projects,
ii) tracking long-term needs of the Projects,
iii) preparing updates on progress relative to 12-month milestones for each project and
iv) facilitating the career development of junior investigators.